Folding, Misfolding, and Function of PMP22

Project Summary
Charcot-Marie-Tooth Disease (CMT) is a common debilitating hereditary peripheral neuropathy. The
hallmark of CMT pathology is severely defective PNS myelin. There is currently no treatment or cure for
this disease. Roughly 75% of all cases of CMT are caused by Schwann cell overexpression of wild type
(WT) peripheral myelin protein (PMP22) due to trisomy (type 1A CMT), underexpression of PMP22 (for the
WT/null case), or genetically dominant heterozygous (WT/mutant) mutations that alter the PMP22 protein
sequence (type E CMT or the more severe Dejerine-Sottas Syndrome--DSS). Important questions remain
regarding the molecular mechanisms by which these different classes of defects in PMP22 result in
different forms of CMT. Here we propose to address key outstanding questions regarding the molecular
bases for the different forms of CMT.
Aim 1. How does the trafficking and mis-trafficking of WT PMP22 under CMT1A WT
overexpression conditions differ from a folding-defective DSS mutant form of PMP22? We will test
the hypothesis that misfolded WT PMP22 ends up in the cytosol, whereas DSS mutants such as L16P
PMP22 are trapped in the ER or ER-to-Golgi intermediate compartment (ERGIC).
Aim 2. Determine the role of the BAG6 complex (BAG6/GET4/UBL4A) in the cytosolic trafficking
of WT PMP22. Our preliminary data suggests that WT PMP22, but not DSS mutant forms of PMP22
interacts with the cytosolic BAG6 complex. This aim will test the hypothesis that the BAG6 complex
serves as a holdase for misfolded WT PMP22 to facilitate its healthy shuttling to the proteasome, but that
excess PMP22 in CMT1A overwhelms the proteasome, resulting in formation of aggresomes, which are
eventually degraded by BAG6-induced autophagy.
Aim 3. Determine if excess WT PMP22 inhibits specific proteasome complexes and/or induces
phosphorylation of eIF2α in myelinating SCs. Prompted by our preliminary data, this Aim will test the
hypothesis that overexpression of WT PMP22 in SCs inhibits the 26S proteasome and activates an
integrated stress response (ISR), resulting in phosphorylation of eIF2α to suppress protein translation.

Public health relevance
Narrative Charcot-Marie-Tooth Disease (CMTD) is a peripheral neuropathy that afflicts roughly 1 out of every 2500 people and for which there is no cure or therapeutic drug. The most common forms of CMTD are caused by genetic defects affecting intracellular trafficking of the protein peripheral myelin protein 22 (PMP22). The goals of this project are to determine by exactly what pathways the PMP22 traffics in the cell under both healthy and pathological conditions, as well as to examine how interactions with other proteins impact PMP22 trafficking.